PEG-RHUMGDF IN NON-SMALL CELL LUNG CANCER

This is a randomized, placebo-controlled, dose-escalating, phase 1 trial evaluating the safety and biologic activity of pegylated recombinant human megakaryocyte growth and development factor (PEG-rHuMGDF) in previously untreated patients with non-small cell lung cancer. All subjects are ongoing in outpatient follow up.